ORION: Oncology Research Integration using OHDSI-based NLP (NCI Cancer Informatics Scholar)

PROJECT SUMMARY
The Herbert Irving Comprehensive Cancer Center (HICCC) was designated as a National Cancer Institute
(NCI) Cancer Center in 1972 and gained comprehensive status in 1979. The HICCC is the critical driver of
cancer scientific research, clinical trials, innovative patient care, cancer education and training and community
outreach at Columbia University's Irving Medical Center (CUIMC) and NewYork-Presbyterian Hospital (NYPH).
During the current project period (2014-present), CUIMC and NYPH committed $415M for the following: (1)
new research initiatives in basic, translational, clinical and population sciences with >50 strategic faculty
recruitments; (2) new and expanded facilities for laboratory research, dry bench research and clinical activities;
(3) major faculty recruitments; and, (4) support of the HICCC's administrative core. A major aspect was the
recruitment of Anil K. Rustgi, MD as the HICCC Director in late 2018. Rustgi has the unequivocal authority over
cancer research space and cancer care facilities and accompanying substantial resources through the
transformative Irving Family Trust Gift, further reinforced through his dual roles as Associate Dean of Oncology
(CUIMC) and Chief of Cancer Services (NYPH). Over this project period, there was a greater focus upon
transdisciplinary cross-cutting scientific themes that catalyzed the restructuring of the scientific research
programs encompassing 175 members from 34 Departments and six Schools: Cancer Genomics and
Epigenomics; Tumor Biology and Microenvironment; Precision Oncology and Systems Biology; and, Cancer
Population Science. Importantly, Rustgi created units dedicated to Community Outreach and Engagement
(COE) and Cancer Research Career Enhancement (CRCE) and enhanced the 12 Shared Resources. The
Research Programs engendered impactful science with 3,399 publications of which 626 were intra-
programmatic and 456 were inter-programmatic. Total NCI funding is $26M and cancer-relevant funding is
$92M. The HICCC is requesting CCSG support of $4.1M per year (total DC) for the next project period.

Public health relevance
Project Narrative By extending an OMOP-based NLP pipeline into the cancer domain, we will make it possible to extract essential details about breast cancer and oligodendroglioma, such as cancer stage or molecular subtype, from clinical notes within the EHR and represent this information as structured data elements within the OMOP CDM. This work will also map OMOP standards to FHIR to enable researchers across the US and around the globe to conduct multi-site, large-scale analysis using essential cancer details that have been extracted from clinical notes.